The Jackson Laboratory Knockout Mouse Production and Phenotyping Project (JAX KOMP2)

PROJECT SUMMARY The current KOMP2 workflow does not enable phenotype data to be captured if the null mutation results in dominant lethality and founder mice are not produced. This subset of haplo-essential genes is thought to comprise up to 15% of the genome and is highly enriched in human disease. Here we propose an efficient and low-cost pipeline to annotate the phenotypes of haplo-essential genes, providing key data for researchers and clinicians with an accelerated rate of phenotype discovery compared with our current pipelines.

Public health relevance
PROJECT NARRATVE The Knockout Mouse Phenotyping Program (KOMP2) seeks to create an encyclopedia of gene function for the ~20,000 genes in the mouse and to ultimately create a resource for understanding gene function in humans. The Jackson Laboratory (JAX) will contribute to this goal by efficiently generating knockout lines and sharing functional data for 1,500 mouse genes. The JAX team will enhance the value of these data by linking them with current genetic and biological knowledge, enabling the scientific community to discover the roles of these genes in human health and disease.